Developing Consensus on a Practical Framework for Variant Reclassification and Recontact

PROJECT SUMMARY/ABSTRACT
Over a 5–10-year period, between 6% and 15% of germline variants undergo reclassification, a process by
which the clinical meaning of a given variant is recategorized based on updated evidence. Accurate and
definitive variant classification is a critical component of clinical genetic testing, especially as test indications
have broadened over time and more genes are being interrogated per test. Reclassification occurs frequently
in clinical practice today and has well-demonstrated clinical utility. While consensus exists about the
importance of and need for guidance regarding variant reinterpretation, reclassification, and patient recontact,
the field of medical genetics is ablaze with debates over the nature and extent of stakeholder responsibilities
on these issues. We propose to use deliberative research to construct a framework of principles that can
provide practical guidance for ongoing policy development as genomic science evolves. Our research is
directly responsive to numerous calls to action to develop standardized processes and guidelines in
reinterpretation, reclassification, and recontact. We will achieve our goals through the following aims: Aim 1:
Explore stakeholders’ views (and prime them) regarding key questions related to variant reinterpretation,
reclassification, and recontact. Aim 2: Identify underlying values and principles and clarify areas of agreement
and disagreement among stakeholder groups. Aim 3: Develop expert consensus on proposed solutions to the
key questions. The proposed project will utilize a complementary set of methodologies to provide a
comprehensive overview of variant RRR (Aims 1 and 2); a durable framework of practical principles (Aim 2) to
guide future policy as genetic knowledge evolves; and a set of concrete, expert-derived policy
recommendations (Aim 3). Generation of a durable framework of principles that can guide ongoing policy
development in medical genetics – rather than a set of policy recommendations with limited shelf-life- is an
important innovative element of the proposed work.

Public health relevance
PROJECT NARRATIVE The goal of this study is to generate supportive scientific evidence and develop concrete policy recommendations around germline variant reinterpretation, reclassification and recontact to standardize the practice of genomic medicine. By achieving the aims of this study, the proposed project will meet the critical need to provide considered, expert-driven policy recommendations that represent the views of a representative body of genomic stakeholders. Cross-specialty deliberation, public input, and longitudinal engagement are key aspects of the study.